Untangling the Inner Workings of the Mycobacterial Cell Envelope

PROJECT SUMMARY
Mycobacteria are the exception to many rules for bacteria. Their cellular structure and the way they grow defy
common assumptions. Moreover, their exceptional cell biology is believed to underlie exceptional behaviors
such as tolerance to drugs. Drug tolerance is general to mycobacteria, but is especially relevant to the
eradication of pathogenic species such as Mycobacterium tuberculosis, which causes tuberculosis. The unique
characteristics of mycobacteria could offer attractive avenues for more effectively targeting them in infection.
For example, their cell envelope is a multilayer cellular structure that is one of the most complex in the bacterial
kingdom and contributes to the inherent resistance of mycobacteria to antibiotics. However, very little is known
about how the cell envelope is made during growth and division. In particular very little is known about the
assembly of the outer membrane-like barrier known as the mycomembrane, which is a defining feature of
mycobacteria due to its unusual composition and extreme hydrophobicity. The rationale of this proposal is that
uncovering such fundamentals is essential to understanding mycobacterial survival in the challenging
environments that they encounter. The objective of this research program is to uncover mechanisms of
mycomembrane biogenesis and the connections to cell elongation. The proposal addresses three questions:
Q1: How do mycobacteria export lipids to the mycomembrane?
Q2: How do mycobacteria synthesize the multiple layers of the cell envelope and achieve localized growth
from their poles?
Q3: How do we identify the machinery for essential processes within the mycobacterial cell envelope?
The PI and her team will address these questions through a combination of microbiology, biochemistry, and
chemical biology. A network of collaborations supports this program. The impact of this project is to provide (1)
opportunities for the rational targeting of cell envelope biogenesis for anti-infective therapy and (2) much-
needed tools to investigate mycobacterial cell envelope proteins.

Public health relevance
PROJECT NARRATIVE The proposed project is relevant to public health because gaining fundamental knowledge about mycobacterial physiology and identifying potential pathways for intervention are key initial steps in the development of improved chemotherapeutics against tuberculosis. This research is relevant to the part of the NIGMS mission that supports increasing our understanding of biological processes towards advancing disease diagnosis, treatment and prevention.